Ion Mobility Spectrometry- quadrupole Time-of-Flight (IMS-qToF) Mass Spectrometer

Summary
Biomedical research in the modern age has been revolutionized by the high resolution and high sensitivity
mass analysis provided by state-of-the-art mass spectrometry (MS) instruments. The Lumigen Instrument
Center (LIC) at Wayne State University has a mission to provide researchers at the university and in the
regional area with reliable and diverse user-based MS analysis to elevate their research productivity. As
part of the strategic plan of the Mass Spectrometry Laboratory in the LIC, the Mass Spectrometry Advisory
Committee identified two current challenges for users. First, the substantial down time of a 17-year old
Liquid Chromatography-Time-of-Flight (LC-TOF) instrument has prevented vital high resolution mass
analysis, which has dramatically affected user research productivity. Second, the outdated hardware and
software of a 14 year-old LTQ Orbitrap XL has stalled application to variety of projects. Finally, development
of new methods to address the unique needs of individual users is limited due to the absence of new and
powerful technologies, including Ion Mobility Spectrometry (IMS).
To address these challenges, this application requests funds for an Ion Mobility Spectrometry- quadrupole
Time-of-Flight (IMS-qTOF) Mass Spectrometer at Wayne State University. The instrument will significantly
enhance research accomplishment in mass spectrometry (MS) on our campus. First, the IMS-qTOF will
replace outdated and failing MS instruments for routine high-resolution analysis of small molecules and
biomolecules. Second, the instrument will provide the only mass spectrometer in a shared facility on campus
with IMS capability, which will enable NIH-funded researchers to expand and transform their research
activities. The multiple capabilities of the instrument will include Top-Down and Bottom-Up Protein
identification, protein adduct and conjugation characterization, protein conformational studies, biomarker
discovery, drug-antibody characterization, accurate mass determination, and multi-omics workflows. The
instrument will support the research programs of at least 19 users at Wayne State University and the
regional area, which include chemists, biologists, environmental scientists, and medical researchers. The
IMS-qTOF will be housed and maintained in the Lumigen Instrument Center (LIC), which has strong
institution support from the University, the Office of the Vice President of Research, and the College of
Liberal Arts and Science. The LIC has an exemplary record of instrument stewardship, with dedicated staff,
facilities, and management to support the long-term use of the instrument. Importantly, the user-focused
structure of the LIC will promote development of a unique array of new methods for each user’s individual
research projects. The acquisition of an IMS-qToF is aligned with the long-term strategic plan of the Mass
Spectrometry Laboratory at the LIC, which seeks to provide state-of-the-art and reliable MS instruments to
implement innovative user-initiated projects at Wayne State University and local area community.

Public health relevance
Narrative Modern high resolution and high accuracy mass spectrometers have revolutionized biomedical research with the ability to characterize small quantities of drug and biomolecule compounds. This application seeks to acquire an Ion Mobility Spectrometry- quadrupole Time-of-Flight (IMS-qToF) Mass Spectrometer at Wayne State University to significantly augment research productivity on the Wayne State University campus and in the regional community.